Establishing Mechanisms of Benefit to Reinforce the Alzheimer's Care Experience AD/ADRD Roybal Center: EMBRACE

Establishing Mechanisms of Benefit to Reinforce the Alzheimer's Care Experience AD/ADRD Roybal Center: EMBRACE https://reporter.nih.gov/search/UduQofL_lECIBvB5y-nUoA/project-details/10875109
Abstract Text
Program Summary/Abstract-Administrative Core Robust research infrastructure capable of advancing the science of dementia care interventions in the home and community is necessary. Such infrastructure should reflect the integration of concentrated and synergistic areas of scientific expertise encompassing all components of the NIH Stage Model, dementia care interventions, community engagement, and recruitment and retention. Our proposed AD/ADRD Roybal Center, Establishing Mechanisms of Benefit to Reinforce the Alzheimer’s Care Experience (EMBRACE), addresses this need by assembling an interdisciplinary team that synergizes these areas of expertise to establish a strong research infrastructure to facilitate the science of mechanistically driven dementia care interventions. The primary objective of the Administrative Core (AC) is to provide governance, oversight, and systematic coordination of activities of EMBRACE. The AC will provide focused leadership and structure for all EMBRACE activities including its solicitation, review, awarding, and monitoring of clinical trials; coordination of the External Advisory Committee (EAC); evaluation of the overall Center and progression of awarded Investigators; coordination with the Roybal Coordinating Center to advance the overall mission of NIA’s Roybal Program; and dissemination and network building with other Roybal and NIA-funded Centers. Together, these activities will create a vibrant community of scientists engaged in testing mechanisms of action in dementia care interventions as emphasized in RFA-AG-24-007. The Specific Aims of the EMBRACE Administrative Core are to: 1) Provide governance and administration of EMBRACE; 2) Support the scientific activities and functions of EMBRACE by coordinating solicitation and review of applications with the Behavioral Intervention Development Core; and 3) Facilitate the development of research networks and collaborations within and beyond EMBRACE that advances a mechanistic science of dementia care interventions. In accomplishing these Aims, EMBRACE will in turn achieve its objective of generating extensive and substantive research capacity to advance the development and advancement of potent and mechanistically oriented dementia care interventions in home and community settings across the NIH Stage Model.

Public health relevance
Establishing Mechanisms of Benefit to Reinforce the Alzheimer's Care Experience AD/ADRD Roybal Center: EMBRACE: https://reporter.nih.gov/search/UduQofL_lECIBvB5y-nUoA/project-details/10875108 Public Health Relevance Statement Project Narrative-Overall The primary objective of the Establishing Mechanisms of Benefit to Reinforce the Alzheimer’s Care Experience AD/ADRD Roybal Center (EMBRACE) is to provide scientific infrastructure to support the testing of mechanisms in tailored home and community dementia care intervention trials across Stages 0-V of the NIH Stage Model. The Aims of EMBRACE are as follows: 1) Leverage the extensive expertise of EMBRACE to attract and support early stage to expert Investigators to test mechanistically driven dementia care interventions across the NIH Stage Model; 2) Advance the science of testing mechanisms of tailored dementia care interventions in home and community settings; and 3) Conduct a robust evaluation of EMBRACE to ensure appropriate progress of supported trials.